Outreach Core

OUTREACH CORE SUMMARY The CCMI’s Outreach Core will use a multifaceted approach to promote the use of systems biology in cancer research and clinical translation. We will also devote significant efforts to educating the general public, from children to adults and including patients, patients’ families and patient advocates. The result will be a motivated community of cancer systems biology researchers, an enthusiastic next generation of scientists and clinicians, and a more informed general public open to supporting further systems biology research. First, to expand the community of cancer systems biology researchers at the University of California, the CCMI will play a major role in recruiting new faculty and training junior scientists at both UCSF and UCSD. We have and will continue to work closely with our institutional leadership to recruit new faculty members with expertise in cancer systems biology. We will draw on significant matched institutional support to start a new program of Cancer Systems Biology Trainees, enabling us to recruit and support top graduate students and postdoctoral fellows at both campuses. Second, the CCMI will organize a wide array of educational opportunities for the academic community. As our flagship event, we will organize an annual Cancer Network Biology Symposium, featuring talks world leaders in the field. To build local, technical expertise, we will organize CCMI Workshops, which will provide hands­on, expert advice for learning and applying bioinformatics tools and systems biology techniques to cancer research. The CCMI will also provide support to numerous seminar series at both UCSF and UCSD campuses. All of these educational opportunities will be open to the entire research community. Third, the CCMI will support an array of public outreach activities in recognition of the vital role that the scientific community plays in educating lay people and influencing public opinion. These activities will leverage the strong partnerships we have established with institutions of proven track­records. This includes science museums such as the Exploratorium in San Francisco and the Reuben H. Fleet Science Center in San Diego California, science festivals such as the Bay Area Science Festival and the San Diego Festival for Science and Engineering, and the Ida & Joseph Friend Cancer Resource Center to offer educational opportunities to cancer patients. These events will both educate the public and provide members of the CCMI opportunities to share their enthusiasm and excitement for science and medicine. For remote learners, we will partner with iBiology to leverage their expertise in video production to showcase how we are using the tools of systems biology to combat cancer. Finally, we will build a comprehensive website (ccmi.org) to disseminate information about our research and training activities, and to enable widespread dissemination of resources. Visitors to the site will be provided with up­to­date information about the research projects, links to sites for downloading primary data sets and bioinformatics tools, and online forms to enroll in CCMI events.